Pilot Projects Program

PILOT PROJECTS PROGRAM: PROJECT SUMMARY/ABSTRACT
The Southern California Environmental Health Sciences Center (SCEHSC) Pilot Projects Program, led by the
Center Director, is an integral part of the SCEHSC’s mission to develop the scientific knowledge base,
investigator teams, and community engagement needed to reduce the burden of diseases and disability from
environmental impacts. The Pilot Projects Program acts as a springboard for emerging environmental health
sciences research questions, an incubator for junior investigators’ careers, and an opening for establishing new
multidisciplinary collaborations in environmental health research by funding one-year projects up to $50,000. We
have an established administrative process responsible for announcing the program, conducting review, and
making funding decisions that will continue to function in this manner for the proposed renewal period.
Throughout the current cycle, the Pilot Projects Program has been extremely successful at supporting the
development of new research areas and directions, providing preliminary data to support larger grant
applications, and encouraging new collaborations in environmental health research. In the renewal period, we
plan to build on the Pilot Projects Program’s success at attracting exemplary applications from current SCEHSC
investigators and individuals new to environmental health sciences, as well as nurturing the careers of the most
promising early-stage environmental health sciences investigators in Southern California.